Evaluation of Small-Fiber Polyneuropathy in Youth

Project Summary/Abstract
This is a renewal application for the R01NS093653 award that has been funding the Oaklander lab's research
on small-fiber neuropathy. SFN is a recently recognized peripheral nerve illness that causes chronic pain,
usually starting in the feet and spreading up, difficulty completing routine activities and gastrointestinal distress.
In 2013, the team studied 41 children and young adults, unexpectedly reporting evidence of SFN in most. Until
then, SFN was known only in older adults with diabetes, chemotherapy or other toxic exposures and serious
diseases. The lab had discovered a new condition–early onset SFN (eoSFN). For many, it forced withdrawal
from school or work, derailing young patients' life trajectories. When the lab then reported that 41% of adults
with fibromyalgia also had objective evidence of SFN, implying there might be > 100,000 SFN patients globally,
R01NS093653 funded them to develop standardized tools for collecting data about symptoms (the SSS small-
fiber symptom survey) and exam abnormalities (the MAGNET Mass General Neuropathy Exam Tool) and a list
of best blood tests to screen for potential causes. The PI also directs Mass General's neuropathology lab that
confirms SFN diagnoses by examining tiny skin biopsies from patients' lower leg to measure the density of
small-fiber nerve endings and compare it to biopsies from normal. So the lab built the Neuropathy Registry, a
relational database now containing downloaded electronic medical records plus clinical and research testing
from >6500 people evaluated for SFN. It currently includes 6394 biopsy results and >1000 SSS and MAGNETs
with more than 1000 new patients added yearly. The PI is also part of the NIH and FDA funded CONCEPPT
committee of experts now publishing the 1st formal case definition for SFN, with inclusion requirements for
research. These require specific abnormalities that are already captured by the SSS, MAGNET, and skin
biopsy. Now Aim 1 proposes to use Registry participants plus new patients and healthy volunteers to adapt
and validate the SSS and MAGNET for general medical use by any doctor and for use in children. Aim 2 will
collaborate with the Food and Drug Administration's Biomarker Qualification Program to obtain an FDA ruling
on lab requirements to improve the quality and accuracy of skin biopsy testing. Aim 3 begins whole-genome
study of causes and risks for SFN. It recruits Registry patients with CONCEPPT-defined SFN and adds more
via the lab's NeuropathyCommons website and its global collaborators. Dr. Züchner's U. Miami neurogenetics
lab will analyze the genomes of qualifying participants to study known and unknown genes that cause or
increase risk for SFN. More genetic neuropathies are becoming treatable and Dr. Oaklander helped publish the
1st effective treatment for HSAN1. The final and future goal is to track large numbers of SFN patients and
families using secure web and cell-phone versions of the SSS and MAGNET and mailed-in skin biopsies.
These will allow them to map SFN's symptoms and natural history, identify new causal pathways and potential
treatments, and track children and newly treated patients to monitor long-term outcomes and treatment effects.

Public health relevance
This is an application to renew current R01 award that has funded our research on small-fiber neuropathy (SFN), which is increasingly linked to fibromyalgia and mysterious multi-symptom illnesses that include unexplained widespread pain, intolerance of exertion and gastrointestinal discomfort. We now propose to revise and optimize the tools we developed for SFN diagnosis for use by doctors and patients around the world and to work with the U.S. Food and Drug Administration to get their Qualification recommendations on how to improve the skin biopsies used globally to confirm SFN diagnoses. We will also collaborate with a leading neuropathy geneticist to sequence the genes of SFN patients we select with our tools that have genetic mutations likely to contribute fundamental knowledge about SFN.